Imperial County Clinical Research Network for Health Equity

PROJECT SUMMARY
This 5-year effort titled “Leveraging a Regional Clinical Practice Research Network for Health Equity in the Rural,
Border Region of Imperial County, California (Imperial County Clinical Research Network)” seeks to advance
minority health and health disparities research by establishing the personnel and systems (policies and
procedures) infrastructure to support clinical research within a regional medical center that serves a rural, border
community in Southern California. It accomplishes this by bringing together three primary organizations and their
respective leaders to develop a disease-agnostic research agenda consistent with the needs of patients, diverse
clinicians and multi-sectoral community stakeholders. Infrastructure will be developed to support both
observational (e.g., cohort studies; secondary analyses using electronic medical record [EMR] data) and
intervention (from efficacy to effectiveness trials) research. During the UG3 phase, we propose to develop the
research infrastructure to support the implementation of a pragmatic trial as this provides the strongest possible
infrastructure for supporting PP2, which will be determined through a competitive process. The UG3 phase also
will advance data sharing activities including identifying a set of common data elements across Network sites,
and developing and testing protocols and systems for sharing data, including EMR data from multiple systems.
During the UH3 phase (Y3-5), both PPs will be launched following final approval from the Multidisciplinary
Research Council and the SDSU IRB committee. PP1 proposes to test a robust Lactation Support Program to
promote engagement in prenatal care and exclusive breastfeeding to ultimately reduce the rates of childhood
overweight and obesity in Imperial County. The UH3 phase will continue to advance data sharing and promote
dissemination through the development of protocols and systems for data verification, data harmonization, and
meaningful interpretation of data given contextual factors (e.g., language of administration). The proposed
timeline plans for data sharing and harmonization to occur with the PPs as early as possible (here in Y3), and
with sufficient time at the end to complete final follow-up data collection from participants, and data submitted to
the Coordinating Center in Y5. All of these efforts will be guided by the involvement of a Patient Advisory
Committee (5 members), a Clinician Advisory Committee (15 diverse clinician types), and a Community
Stakeholder Committee (12 diverse sector members). The ultimate goal of this effort is to identify feasible,
sustainable, and translatable approaches to promote health and well-being in rural, border communities.

Public health relevance
Public Health Relevance Section Transforming the process by which academic researchers, healthcare system leaders, clinicians, and other stakeholders (from patients to organizations) determine what research questions to ask is essential for addressing the health and healthcare needs of rural populations. This transformation is only possible with an infrastructure that supports involvement in the research identification, selection, implementation, and dissemination processes. This application seeks to build on the efforts of healthcare system located in a rural community in California to inform new approaches for supporting the knowledge transfer process through a clinical research network.